ROC StARR: Health and Immune Function Across the Lifespan

Physician-scientists bring a unique perspective to biomedical research, informing clinically inspired basic
science questions (bedside-to-bench), translating fundamental research back to the clinic (bench-to-bedside),
and guiding implementation science on behalf of public health (translation to the community). On the other
hand, there are numerous challenges contributing to the declining number of physician-scientists, including
individual (financial debt, length of time for training, balance of clinical productivity and protected time for
increasingly competitive funding), institutional, and national factors. Robust research programs during
residency can catalyze the development of physician-scientists poised to ask fundamental questions informed
by clinical insights which will be crucial for advancing discovery in NIAID mission-critical immune mediated
diseases in the coming decades. The University of Rochester (UR) has a long history of support for trainees
along the physician-scientist continuum, with a medical scientist training program in its 50th year, Physician
Scientist Training Program (PSTP) in Internal Medicine (IM), and well-established research tracks in the
participating residency programs (Medicine, Pediatric, Med-Peds, and Dermatology). The primary goal of this
multidisciplinary ROChester Stimulating Access to Research during Residency (ROC StARR) Health and
Immune Function Across the Lifespan R38 is to train a diverse pool of next-generation physician-scientists to
lead the development, implementation, and evaluation of new clinical modalities to diagnose, treat and prevent
autoimmune, allergic, inflammatory, and infectious diseases across the age spectrum from infants to older
children to adults to the aging population via the following Aims: 1) recruit an exceptional, diverse pool of
Medicine, Pediatric, and Dermatology Residents and provide them with high quality, rigorous training in 3
defined pillars of translational, clinical, and health equity research through comprehensive didactics and team
science initiatives, 2) provide 1-2 years of mentored research with the support of a multidisciplinary physician-
scientist focused mentorship team uniquely suited to instill in our trainees the in-depth knowledge and skills
needed to conduct cutting-edge research in autoimmune, allergic, and infectious diseases with high clinical
impact, 3) develop individualized career development plans and an infrastructure to foster the physician-
scientist trajectory from resident to fellow to faculty with the goal of expanding the number and diversity of well-
trained residents performing research in immune-mediated diseases, and 4) perform robust evaluation and
tracking to demonstrate the impact of the StARR. ROC StARR will be led by PDs Jennifer Anolik, MD, PhD
(Medicine) and Kirsi Järvinen-Seppo, MD, PhD (Pediatrics) who have a longstanding history of clinical,
education and research collaboration and have strategically assembled a team of 35 multi-disciplinary
physician-scientist faculty preceptors to support two to four Resident-Investigators each year with thematic
emphasis on immune responses during development, aging, and disease.

Public health relevance
PROJECT NARRATIVE The primary goal of this ROChester Stimulating Access to Research during Residency (ROC StARR) Health and Immune Function Across the Lifespan R38 is to leverage the strong infrastructure and collaborative research environment at the University of Rochester to provide at least 12 months of training in 3 defined pillars of translational, clinical, and health equity research for resident physicians from the participating residency programs (Medicine, Pediatric, Med-Peds, and Dermatology). The long-term goal is to expand the pool of next-generation physician-scientists to lead the development of new approaches to diagnose, treat, and prevent autoimmune, allergic, inflammatory, and infectious diseases. This goal will be implemented through a core curriculum and team science initiatives individualized to trainee needs, mentored research projects with the support of multidisciplinary physician-scientist mentorship teams, and robust career development plans, building a systematic approach for recruiting and training a diverse cohort of Resident-Investigators conducting clinically informed research in immune-mediated diseases.